The contribution of innate immunity to heterotopic ossification in fibrodysplasia ossificans progressiva

Fibrodysplasia ossificans progressiva (FOP) is a rare, currently untreatable, congenital disease in which skeletal muscle repair is redirected to endochondral bone formation (heterotopic ossification, HO). These pathologies cause pain, muscle destruction, and joint fusion, leading to progressive immobilization and eventually premature death. FOP is caused by a mutation in Alk2 (most commonly R206H) that renders the receptor sensitive to aberrant activation by Activin A (ActA). However, the “flares” that lead to HO appear to be initiated by inflammatory insults, and HO can be reduced in FOP mice by depletion of inflammatory innate immune cells including macrophages. Fibroadipoprogenitors (FAPs), residing in the muscle interstitium appear to be the critical precursors of chondrocytes in FOP. In healthy muscle repair, macrophages secrete TNFα to trigger apoptosis of FAPs at a precise and critical time in the repair process. However, in injured FOP muscles, FAPs survive and differentiate into chondrocytes, suggesting their interaction with macrophages is disrupted. Therefore, this proposal will explore the hypothesis that pro-inflammatory and anti-inflammatory macrophages are critical sources of cytokines that enable survival and expansion of the chondrogenic fibroadipoprogenitors in FOP. Specifically, it seeks to determine the critical source(s) of ActA and what signals pathways in FAPS are disrupted to block their normal apoptotic fate. These studies will be the first to explore the mechanisms by which macrophages interact with chondrogenic FAPs to support chondrogenesis and HO, and they will provide critical insights to the early stages of FOP flares.

Public health relevance
Fibrodysplasia ossificans progressiva is a rare disease characterized by heterotopic ossification of skeletal muscles that leads to immobilization. This project aims to understand interactions of TNFα and TLR signaling between ceretain immune cells (macrophages) and the cells that later form bone during the early stages of heterotopic ossification.